Project 1: Interrogating Distinct Tumor-Initiating Cells in CRC

PROJECT SUMMARY/ABSTRACT: P1. Interrogating Distinct Tumor-Initiating Cells
A major therapeutic barrier in advanced colorectal cancer (CRC) is tumor recurrence after treatment. The
“cancer stem cell hypothesis” posits that rare populations of cancer cells with stem cell characteristics, also
known as tumor-initiating cells (TICs), fuel tumor growth, resist therapy, and repopulate the tumor at distal
sites. In the normal colon, multiple stem cell populations exist in a reserve-to-active continuum. We
hypothesize that distinct TIC populations exist in CRC, and these distinct populations of TICs have different
clonogenic properties and tumor-repopulating potential. Using TICs marked by Lrig1 and Lgr5 to represent
reserve and active TICs, respectively, we will use novel single-cell approaches to investigate the behaviors of
these populations in the context of therapeutic intervention. First, we will determine whether there is a defined
directional hierarchy where reserve TICs give rise to active TICs versus mutual interconversion. Second, we
will determine whether TICs with malignant characteristics pre-exist in the primary tumor or if TICs acquire
these characteristics de novo as a result of treatment. Third, we will determine whether a signature derived
from TIC behaviors provides prognostic and/or predictive information for individuals with CRC. Our
translational goal is to apply a systems approach to predict likelihood of tumor recurrence based on properties
of TIC populations with the long-term goal of using combinatorial pathway alterations to target TIC behaviors.

Public health relevance
PROJECT NARRATIVE: P1. Interrogating Distinct Tumor-Initiating Cells Cancer stem cells, designated tumor-initiating cells (TICs) in this application, are thought to have the propensity to resist therapy and induce tumor recurrence. We will use single-cell technologies to interrogate distinct populations of colorectal cancer TICs in response to therapies. Our goal is to understand how these TICs behave in order to design strategies to inhibit their function(s).